Unraveling the cell divergent roles of Glucocorticoid-Induced TNF-R Related Protein (GITR): A new opportunity to treat atherosclerosis using targeted immunotherapy

SUMMARY
Although preclinical studies have implicated inflammation as a main driver of atherosclerotic disease for the
past two decades, its clinical relevance has only been recently validated in proof-of-concept trials.
Immune checkpoint proteins, including co-stimulatory and co-inhibitory proteins, are master regulators of the
immune response and were originally described to allow cognate interactions between T cells and antigen
presenting cells (APCs). Lately, it has become clear that immune checkpoint proteins are expressed on a plethora
of immune cells, including macrophages. The sequence, the location and the extent of these interactions condition
the very establishment of an immune response and its resolution or chronicity. Understanding the role of immune
checkpoint proteins in CVD is crucial, as immune checkpoints exert cell-type specific actions and signaling in
atherosclerosis and can therefore be targeted specifically.
We have identified an important role for the co-stimulatory immune checkpoint protein Glucocorticoid Induced
TNF-Related Protein (GITR) in atherosclerosis. In human atherosclerotic plaques, we found that GITR expression
is associated with a vulnerable plaque phenotype. Although GITR is well-known to be expressed on T cells, our
preliminary data show that macrophage GITR plays a key role in atherosclerosis. Macrophages in plaques start
expressing GITR in intermediate and advanced stages of atherosclerosis and Cite-seq analysis of the mouse
atherosclerotic aorta showed that GITR+CD68+ cells display the transcriptome of inflammatory macrophages.
GITR-/-ApoE-/- mice display a reduction in atherosclerosis and develop a stable plaque phenotype, due to a
reduction of monocyte recruitment and macrophage activation. Deficiency of GITR did not affect regulatory or
effector T cells. Likewise, LysM-GITRflflApoE-/- mice, but not CD4-GITRflflApoE-/- mice, develop less atherosclerosis.
Deficiency of GITR on macrophages reduces their migration, TNF production, ROS levels and mitochondrial stress.
Elevated plasma levels of sGITR, which we found to be released by macrophages and not T cells, are associated
with the presence of CVD.
We hypothesize that GITR-signaling in macrophages drives atherosclerosis, and that targeting
(macrophage) GITR is a safe immunotherapeutic approach that will ameliorate ASCVD, as GITR deficiency
affects macrophage biology, but not T cell function. We propose to unlock GITR’s full translational potential as
biomarker and immunotherapeutic target for atherosclerosis. In aim 1, we will detail GITR’s macrophage
specific effects and mechanisms in atherosclerosis. In aim 2, we will test the translational potential of our newly
designed GITR inhibitors using a systemic and macrophage targeted nanobiologic approach. In aim 3, we will test
the potential of sGITR as biomarker for CVD.
Knowledge on cell-type specific actions of immune checkpoints warrants cell targeted immune checkpoint-
based therapeutics that attenuate atherosclerosis-specific inflammatory pathways and will cause limited
immune-related side effects, an essentiality to render immunotherapy a relevant treatment modality for CVD.

Public health relevance
NARRATIVE Co-stimulatory immune checkpoints are master regulators of inflammation and exert cell divergent effects. We propose to study the role of Glucocorticoid Induced TNF-R Related protein (GITR), in macrophages in atherosclerosis, and test its potential as therapeutic target in and biomarker for atherosclerotic cardiovascular disease.